Human Epilepsy Genetics - Mosaic Mutations in Focal Epilepsy

Project Summary:
Epilepsy is a debilitating disease affecting 1 in 26 people (3-4% lifetime risk), making it the third most
common neurological disorder in the United States. Antiepileptic drugs (AEDs) remain the mainstay of epilepsy
therapy, but the long-term sequelae of uncontrolled epilepsy, including underachievement, social isolation, and
heightened rates of depression and sudden death, bring into consideration more aggressive strategies for
patients whose disease is recalcitrant to pharmacotherapy.
The most prevalent form of intractable, non-lesional focal epilepsy in adults is mesial temporal lobe
epilepsy (mTLE), and the causal mechanisms of mTLE remain poorly understood. mTLE often starts in
adolescence or early adulthood, often following a history of earlier febrile seizures or head trauma, and often
becoming more intractable with time. Sclerotic changes of the hippocampus (HS) often appear
radiographically. With proper localization, mTLE is amenable to surgical intervention, resulting in seizure
freedom or improvement in up to two thirds of cases.
Our preliminary data, based on the genomic study of these resected tissues samples, implicate somatic
activating variants in multiple RAS pathway genes in mTLE. The major goals of this study are to: sequence
larger numbers of mTLE samples resected for epilepsy control, in order to confirm and extend our preliminary
findings on the role of RAS activation in mTLE, and to identify other potential genetic regulators of mTLE;
delineate the transcriptional effects of somatic mutation on specific cell types within the epileptic tissue ;
and to identify the exact cell type(s) that carry mosaic variants, and the transcriptional effects on those variant-
positive cells, compared to surrounding variant-negative cells in mTLE.
Our prior experience in the development, use, and analysis of single cell genomic data, together with
our promising preliminary data on mTLE and the availability of high-quality samples in-hand, indicate a high
likelihood that this study will be successful.
Our proposed work promises to provide valuable insight into the genetic causes of mTLE. It will further
use that information to investigate the molecular mechanisms underlying epilepsy.

Public health relevance
Project Narrative: The goal of this project is to acquire and use information about epilepsy-causing mutations that occur in localized regions of the brain, and within a subset of the brain cells within that region, to better understand the functional causes of epilepsy. We will use newly-developed single-cell sequencing methods to identify which specific types of brain cells harbor the causative mutations and determine how these mutations change the expression of genes within these cells, and in neighboring cells. This study will address fundamental questions that need to be better understood in order to develop targeted therapies for individuals with epilepsy.